Engineering a dynamic three-dimensional in vitro platform for the investigation of human Type 1 Diabetes immunopathogenesis

PROJECT SUMMARY/ABSTRACT
Type 1 Diabetes (T1D) is an autoimmune disease caused by aberrant T-cell mediated targeted destruction of
insulin-producing beta cells in the pancreas, resulting in loss of blood glucose regulation, with increased long-
term risks of vascular and neuropathic comorbidities. Despite the fact that T1D is one of the most studied organ-
specific autoimmune diseases, the various strategies aimed at intervention, prevention, or reversal of this
disease have failed to succeed due to incomplete knowledge about the precise mechanisms of their action, as
only peripheral assessments of systemic impacts (e.g., circulating cytokine changes, C-peptide levels) are
feasible. This lack of mechanistic understanding of these interventions, as well as substantial time and cost of
clinical trials, is a profound obstacle in improving therapeutic outcomes. To address these significant knowledge
gaps, there is a substantial clinical need to develop human-based ex vivo systems capable of intimately studying
the interplay of islets and immune cells, as well as the contribution of environmental factors on immune cell
activation, homing, and cytotoxicity. The primary hypothesis of this proposal is that the development of an islet-
immune platform has the potential to provide unique insight into T1D, with investigation of activation pathways
and screening of interventional approaches. Thus, the objective of this proposal is to engineer, validate, and
utilize a unique in vitro 3-D platform for the interrogation of human T1D immunopathogenesis by converging
innovative cells with biomaterials, in situ imaging, and microphysiological systems (MPS). Aim 1 will seek to
establish and validate this 3D biomaterial-based co-culture platform. To validate the system, a tiered approach,
building from single antigen murine model cells to human T1D-antigen cells, will be employed. Once validated,
Aim 2 will translate this platform to study human-centric T1D-relevant pathways and interventions. Finally, Aim
3 will seek to integrate spatial and fluidic features by translating the 3D material to an established
microphysiological system (MPS) platform, which will permit the study of T cell migration from a fluidic
microenvironment to the beta cell niche. Results from this proposal should provide a validated and enabling tool
for the study of human T1D-relevant pathophysiology, interventions, and therapeutics. While the proposed field
of application for this platform is T1D, other autoimmune diseases can benefit from this engineered benchtop
platofrm, as they share homologous hallmarks of immune cell dysregulation.

Public health relevance
PROJECT NARRATIVE Despite the fact that T1D is one of the most studied organ-specific autoimmune diseases, the various strategies aimed at intervention, prevention, or reversal of this disease have failed to succeed. The proposed in vitro platform has the potential to bridge the current knowledge gap of the T1D immunopathology through the 3-D investigation of key cellular players and mechanisms of immune activation and progression, which will permit for improved targeted interventions that can delay disease progression or elevate the efficacy of cell replacement therapies.